INTERACTIONS OF THE RENAL DOPAMINERGIC AND RENIN ANGIOTENSIN SYSTEMS

The purpose of this protocol is to determine whether the regulation of sodium and water balance is influenced by interactions between the renal dopaminergic and renin-angiotensin system (RAS).